Simultaneous Hadamard Editing of GABA and Glutathione

Summary
The neurotransmitter GABA and the redox compound glutathione can be measured in the human brain non-
invasively using Hadamard-encoded edited MRS. Such measurements currently suffer from three major
limitations: the confound of transverse relaxation (since edited MRS requires long echo times); incomplete
spectral resolution between metabolites and the macromolecular background; and inadequate/inflexible
modeling and quantification software. The overall goal of this R01 renewal period is to develop Hadamard-
encoded edited MRS of GABA and Glutathione into a robust and reproducible tool for neuroscience.
Building on the successful development of HERMES in the first funded period we will develop interleaved
multi-spectrum acquisitions to improve robustness to changes in transverse relaxation and the macromolecule
baseline and develop multi-spectrum linear combination methods within our software Osprey, including
building a demographic model of the macromolecular background spectrum. This project will culminate in a
patient-based validation study in subjects with Alzheimer’s Disease. The resulting data acquisition and analysis
tools will be made available for dissemination to the clinical neuroscience and neuroimaging communities.

Public health relevance
Project Narrative GABA and Glutathione are key brain chemicals, involved in communication and antioxidant defense respectively. This project will develop new experimental and data processing tools to allow GABA and GSH to be measured at the same time using an MRI scanner.